Dispositional Negativity and the Pavlovian Control of Active and Passive Defensive Behavior - Supplement

PROJECT SUMMARY / ABSTRACT
The purpose of this administrative supplement is to support Dr. Allen’s transition from a mentored career
development K01 award to research independence as he experiences a critical life event. This supplement will
ensure the continuity of Dr. Allen’s research program by providing funds for a postdoctoral associate who can
oversee recruitment and study visits during Dr. Allen’s planned time off, contribute to the creation and
maintenance of data processing and analysis pipelines, and assist in the preparation of planned manuscripts.
Adding a postdoctoral staff member will be impactful to Dr. Allen’s progress because his study involves a
complex dimensional recruitment strategy and has ambitious sample size targets would be hampered by a
slowdown in recruitment during this critical life event. The study also requires continuous maintenance of
preprocessing and analysis pipelines for multimodal data, including functional neuroimaging,
psychophysiology, experimental data. This supplement support comes at a critical juncture in Dr. Allen’s
career, during which he will be preparing his first R01 submissions. Increased staff support will enable Dr. Allen
to bring existing planned manuscripts to publication in a timely manner, allowing him adequate time to develop
future R01 submissions, and supporting his retention in biomedical research as he transitions to full research
independence.

Public health relevance
Dispositional negativity is a transdiagnostic risk factor for psychopathology defined by a heightened reactivity to threat and punishment that manifests in the form of frequent and intense negative affect. The present application leverages the capabilities of modern computational neuroscience to examine the latent decision processes that contribute to maladaptive threat responding in individuals with elevated dispositional negativity. Understanding the neurocomputational basis of dispositional negativity will help to facilitate the development of behavioral and computational indices that can be targeted for modification in novel transdiagnostic interventions.